Tetrad: Genetics, Cell Biology, Biochemistry and Molecular Biology Training Grant

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The mission of the Tetrad program is to transform a group of bright and motivated trainees into independent, innovative, and rigorous leaders in academic science, biotechnology, and affiliated disciplines. Our mission requires balancing disciplinary specialization, which is essential for depth and rigor, with the flexibility to think broadly across disciplines, which drives scientific breakthroughs. Towards this goal, the Tetrad program provides training in the fundamental principles of Genetics, Cell Biology, and Biochemistry and the use of these principles to practice the scientific method across disciplines and with rigor. The approaches and concepts in these areas are applicable to nearly every aspect of modern biology. Therefore, we believe that by building a solid foundation in these core areas, we can best equip our trainees for the fast pace of biomedical discovery and the expanding landscape of science related career options. Thus, our training does not get obsolete with new technological innovations or changing biological paradigms, but instead contributes to driving such breakthroughs by empowering students to engage in curiosity driven research. The emphasis on fundamental principles is complemented with exposure to cutting-edge biomedical findings and techniques to increase our students’ curiosity and foster their ability to tackle questions of broad significance. Our mission also requires training in essential professional skills, such as effective and accurate communication of science, an ability to work in multi-disciplinary teams and an ability to identify a productive career path. Therefore, training activities such as proposal writing courses and career development workshops are woven throughout the program. Finally, our mission requires that efforts to enrich the biomedical workforce do not rely simply on increased recruitment of talented individuals but also depend on efforts to ensure their continued success. Therefore, activities such as training our program faculty in best practices for effective mentorship are essential program components.
The broad range of scientific problems studied by the 79 training faculty and their strong commitment to graduate training has enabled Tetrad to provide an environment that nurtures the excitement and curiosity that lies at the heart of doing science and empowers all our trainees to be impactful members of the biomedical workforce. We plan on appointing 13 students for a duration of 2 years. Therefore, we request a total of 26 annual slots as we anticipate that each year, we will have 13 first year students and 13 second year students on this training grant. Trainees will be chosen from a highly qualified pool of students.

Public health relevance
Project Narrative Two aspects of the training program are relevant to public health. First, students are trained in basic science approaches that are fundamental to modern biomedical research. Second, all of the research projects have the potential to improve the understanding and treatment of human health problems, ranging from cancer to aging.